Computational Neuroscience of Language Processing in the Human Brain

The neural architecture of language is the foundation for the highest form of human interaction. Prior work has
delineated a network of frontal and temporal brain areas that selectively support language processing, but the
precise computations that underlie our ability to extract meaning from sequences of words have remained out
of reach. Recent breakthroughs in natural language processing and machine learning have led to the
development or artificial neural network (ANN) models of language that perfrom remarkalbly well on previously
intractable tasks, providing the first computationally precise models of how these functions might be solved by
the brain. However, the standard approaches in human cognitive neuroscience lack the spatial and temporal
resolution necessary for precise comparisons to computational models. Here we propose to collect large sets
of neural responses to language stimuli from the human brain using the only method up to the task-human
intracranial recording, and to bring the recent advances in computational neuroscience and machine learning
to bear on the ultimate scientific quest of understanding uniquely human linguistic ability. In Aim 1, we build on
a strong foundation of our earlier fMRI work to tackle a fundamental distinction between two key components
of language-understanding word meanings (lexico-semantic processing) and connecting those meanings into
phrases and sentences representations (syntactic processing). This distinction will be tested across four
controlled paradigms. In Aim 2, we will extend the results from Aim 1 to rich naturalistic materials, testing for
sensitivity to word meanings vs. hierarchical syntactic structure in predicting upcoming words. We will also
supplement this hypothesis-driven approach with a data-driven search for structure in neural responses to
language using innovative analytic techniques recently developed in the study of auditory cortex. Finally, in
Aim 3, we will use human intracranial responses to language stimuli to test computational models of language
understanding. In recent work, we tested a large number of ANN language models and found that the most
powerful 'transformer' models accurately predict neural responses. Here we harness the precision of human
intracranial recordings, a large set of diverse linguistic materials-selected and created to discriminate among
candidate ANNs using novel state-of-the-art design optimization approaches-and controlled minimal-pair
network comparisons to powerfully test computational models of language understanding. In line with current
emphasis in the field on robust, replicable, and open science, the full dataset (1,500+ sentences in each of ~40
participants) will be made public, enabling many analyses beyond the ones proposed here, thus turbo charging
the quest to understand the neural computations underlying language processing and moving the field forward
for years to come. This work will set the stage for the most comprehensive picture of the neural architecture of
language and synergize with parallel ongoing advances in network modeling of human cognition, making it
possible for the first time to discover the neural codes and computations underlying human language.

Public health relevance
Language is a signature human cognitive skill, but the precise computations that support language understanding remain uknown. Here we combine the highest-quality human neural data available (intracranial recordings) with advances in computational modeling of human cognition to shed light on how we construct rich and complex meanings from sequences of words. A model that can accurately predict neural responses to language can critically inform our understanding of both language development and linguistic disorders, though manipulations of model training regimens or lesioning the architecture and examining the consequences.